CBMHR Administrative Core

ABSTRACT : ADMINISTRATIVE CORE
Texas Southern University (TSU), the nation's second largest Historically Black College and University is a
comprehensive doctoral Institution of Emerging Excellence that was recently designated by the Carnegie
Classification of Institutions of Higher Education as an institution with “high research activity (R2).” Training
over 8,500 academically and ethnically diverse students each year with ~709 faculty members, TSU is a top
producer of quality health professionals and future generation of talented biomedical research scientists
focused on addressing health disparity concerns of the large underrepresented minority (URM) and
underserved community within our geographical location in the historic Third Ward area in city of Houston.
Faculty expertise in biomedical research at TSU has a long history dating back to the 1986 when the University
was awarded its first NIH-supported Research Centers for Minority Institutions (RCMI), 5-year infrastructure
grant , where pharmacokinetics studies were utilized to evaluate drug-drug interactions of anti-AIDS drugs
which led to a successful Phase 1 clinical trial funded by NIAID. The Administrative Core (ADC) of the
proposed Center for Biomedical and Minority Health Research (CBMHR) will build upon the existing structure
of the current RCMI Program (9/26/2014 – 5/31/2020), which resulted in: 93 publications, 12 awarded grants,
15 patents/submissions and several presentations at international and national meetings. Moreover, the
currently-funded ADC successfully launched a structured faculty mentoring program that significantly
contributed to the productivity and development of junior faculty, resulting in several grant awards (including
NIH and NSF) and publications. Upon renewal, the ADC will build upon current capability and expand its
function to provide administrative leadership, oversight, accountability, integrative coordination,
communication, mentorship, programmatic assessment and evaluation for all CBMHR cores [Research
Infrastructure Core (RIC), Investigator Development Core (IDC), Community Engagement Core (CEC)], and
activities. The specific aims of the ADC are: 1) Provide integrated administrative oversight, logistical support,
centralized resources for CBMHR cores/activities and research projects; 2) Develop and deploy career
enhancement activities for junior faculty and postdocs; 3) Increase productivity of TSU investigators by
fostering synergy through the provision of centralized activities and establishment of a rich collaborative
environment and 4) Deploy a rigorous evaluation and continuous improvement program to maximize CBMHR
impact. The unique and collective strengths of CBMHR cores, innovative research projects, excellent
resources and structured career enhancement program will make it a novel synergistic center, a first-
of-its-kind (at TSU and in the TMC) that will provide comprehensive, integrated and centralized
infrastructure and high quality capabilities for advanced biomedical research innovation and
synergistic community engagement that directly impact minority health and encompass the different
aspects of biomedical discovery and preclinical drug development. This U54 funding is critical to help to
synergize research infrastructure capabilities to bring more young minority investigators into the mainstream
biomedical research and maximally provide the necessary support to our investigators that are addressing the
pressing health concerns and needs of the communities we serve.